Combination Gene Therapy for Treatment of Canine Mucopolysaccharidosis Type I

MPS I, historically known as Hurler, Hurler-Scheie, and Scheie syndromes depending upon degree of central
nervous system (CNS) involvement and velocity of disease progression, is a deficiency of the α-L-iduronidase
(IDUA) enzyme resulting in pansystemic storage of glycosaminoglycans (GAGs). While Hurler syndrome,
which represents the most severe degree of IDUA deficiency and symptomatology, presents in the first year of
life with neurodevelopmental stagnation and subsequent regression, the other forms of MPS I also experience
CNS involvement with dural hyperplasia, spinal canal stenosis, and myelopathy. All forms of MPS I manifest
painful, degenerative joint disease caused by synovial hypertrophy and inflammation, and abnormalities of
chondrocyte proliferation and matrix synthesis. Other MPS I symptoms include hepatosplenomegaly,
cardiomyopathy, valve dysplasia, and aortic root dilatation. Treatments for MPS I, either stem cell transplant
(SCT) or intravenous enzyme replacement therapy (ERT) with recombinant human IDUA, reduce disease
burden and extend life expectancy of MPS I patients, but represent incomplete therapies. SCT poses
significant risks of immunocompromise, graft-versus-host disease, incomplete engraftment, or death. ERT
must be administered repeatedly for the patient’s entire lifetime and does not cross the blood-brain barrier,
rendering it incapable of treating CNS disease. SCT-treated Hurler patients, even with full hematopoietic
engraftment and normal blood IDUA levels, suffer significant cognitive deficits and require rehabilitative
services. Neither SCT nor ERT ameliorate joint contractures and osteoarthritis, leaving patients with daily pain,
immobility, and reduced quality of life. Therefore, there is a clear necessity to develop a single-session therapy
for MPS I which safely, durably, and fully restores IDUA levels throughout the body especially the CNS and
joints, to correct symptoms in multiple key affected tissues. This necessity takes on additional urgency as
increasingly, MPS I is identified in the neonatal period through newborn screening, presenting an opportunity to
provide early treatment and prevent onset of symptoms throughout all organ systems. This study utilizes the
canine MPS I model to evaluate a multimodal gene therapy approach, simultaneously treating with
combinations of intracisternal, intra-articular, and intravenous adeno-associated virus vector carrying copies of
the normal canine IDUA gene. Aim 1 of this proposal will study the ability of this novel approach to safely
generate CNS expression of IDUA enzyme, eliminate GAG storage, and translate to improvement of
abnormalities in brain imaging and cognitive function. Aim 2 of this proposal will evaluate for expression of
IDUA enzyme, clearance of GAG storage in joint synovium and cartilage, and improvement of joint
morphology, reduction of inflammation, and normalization of ligamentous strength. Enzyme expression,
substrate reduction, and pathology will also be assessed in hepatic and cardiac tissues. This study will
generate essential key data informing subsequent clinical trials of multimodal gene replacement therapy in
human MPS I, addressing the unmet need faced by affected patients.

Public health relevance
PROJECT NARRATIVE Mucopolysaccharidosis type I (MPS I) is a genetic disorder which causes serious and progressive symptoms beginning in early childhood, especially the central nervous system with loss of neurodevelopmental milestones, deterioration of neurons, and loss of white matter; and the joints with stiffness, decline in mobility, and painful degeneration. Hematopoietic stem cell transplant, a treatment for MPS I, must be done as early as possible to prevent neurodegeneration, but is risky and does not completely take care of these difficult symptoms, leaving children with intellectual disability and severe deficits performing activities of daily living. The proposed studies will evaluate a multimodal gene therapy approach in the canine model of MPS I to simultaneously remedy multiple refractory aspects of the disease, paving the way towards future therapy for people with MPS I that is less risky, while comprehensively addressing symptoms.